Defining a novel neurocircuit for Stress-Induced Hyperglycemia

Project Summary/Abstract
In emergency situations, such as psychological or physical trauma, glucose is the body’s preferred
source of fuel. Thus, to adapt to the situation the brain orchestrates a rapid increase in blood glucose, termed
“stress-induced hyperglycemia” (SIH). Although SIH is vital to meet the increased metabolic demand of the
brain and peripheral tissues, however, excessive SIH (as occurs in 50% of critically ill patients) increases
mortality risk twofold compared to those with appropriate SIH. Since optimal individual blood glucose levels
and the underlying mechanism of SH are unclear, treatments remain inadequate and limited. Therefore, to
develop more effective and targeted treatment it is critical to understand the mechanism that coordinates SIH.
SIH is achieved through central nervous system mediated sympathetic nervous system (SNS) and
hypothalamic-pituitary-adrenal (HPA) axis activation which mediates release of epinephrine/norepinephrine
and corticosterone to rapidly increase and sustain appropriately elevated blood glucose. The ventromedial
nucleus of the hypothalamus (VMH) controls SIH in addition to several other glucose related functions. To
determine whether specialized SIH-mediated neurocircuitry exists in the VMH, we performed single nucleus
RNA sequencing and identified 6 novel Classes of VMH neurons. Of these, Class 1 is localized to the
dorsomedial VMH, which controls glucose related functions. Class 1 can be further divided into neurons that
express leptin receptor (VMHLepr) and neurons that express Glipr1 (VMHGlipr1) with little overlap. VMHLepr
neurons control energy expenditure, but not glucose mobilization. We thus predicted that VMHGlipr1 neurons
specifically mediated SIH. Indeed, our preliminary data indicate that silencing VMHGlipr1 neurons attenuates the
rise in glucose and corticosterone that normally accompanies restraint stress, a model for SIH, but not other
glucose stimulating stressors such as hypoglycemia or fasting. Therefore, we hypothesize that VMHGlipr1
neurons mobilize glucose in response to psychological stressors through HPA axis-mediated corticosterone
secretion. To test this hypothesis, we will: (1) define the regulatory inputs and circuitry of VMHGlipr1 neurons, (2)
identify the neurocircuitry and hormones modulated by VMHGlipr1 neuron activation, and (3) establish the
mechanisms through which VMHGlipr1 neurons mediate SIH. These studies will define the specialized
neurocircuitry for SIH and set the stage for the development of targeted therapeutics for patients experiencing
excessive SIH.

Public health relevance
Project Narrative In emergency situations, such as psychological or physical trauma, the brain orchestrates a rise in blood glucose to meet the body’s increased metabolic demands. This rise in blood glucose, called “stress-induced hyperglycemia” (SIH), is vital for survival, yet excessive SIH occurs in 50% of critically ill patients and increases the mortality risk by twofold. The goal of this project is to identify the underlying neurocircuitry that drives SIH, providing a foundation for the development of more effective and targeted therapies.